Calcium signaling and autophagy defects in Alzheimer's disease neurons

ABSTRACT
The broad, long-term objective of this grant application is to understand the mechanisms responsible for
autophagy defects in neurons affected by Alzheimer’s disease (AD). Dysregulation of neuronal autophagy play
important role in AD pathogenesis from the studies of both AD patients and animal models. Dysfunctional
calcium (Ca2+) signaling is also a well-established driver of AD pathology. Based on results recently obtained
by our laboratory we proposed a model that casually connects dysregulation of neuronal Ca2+, impaired
autophagy and AD pathology. The main aim of this grant proposal is to test this novel hypothesis. To test this
hypothesis, we will perform experiments with transgenic AD mouse model and will evaluate effects of (1)
clinically relevant ryanodine receptor type 2 (RyanR2) inhibitors; (2) positive allosteric modulators of the sarco-
endoplasmic reticulum calcium ATPase (SERCA); (3) dominant-negative constructs targeting
Serine/Threonine kinase 11 interacting protein (STK11IP). In our measurements we quantify ability of these
manipulations to rescue defects in neuronal autophagy and to exert synaptoprotective and neuroprotective
effects. Results obtained in the proposed studies will provide essential information regarding connection
between Ca2+ signaling and autophagy defects and AD, help to validate novel therapeutic targets for AD
treatment and also provide information about potential lead molecules for development of AD therapeutic
agents.

Public health relevance
PROJECT NARRATIVE The proposed project will have direct and immediate relevance for public health. Alzheimer’s disease (AD) is a major cause of dementia in the elderly and an enormous health problem. Investigation of the role played by autophagy in AD pathogenesis will help to identify novel potential therapeutic targets for treatment of AD. Experiments proposed in this grant will help to validate these targets and also help to evaluate potential novel therapeutic interventions for AD treatment.